Center to Accelerate Translation of Interventions to Decrease Premature Mortality in Persons with Serious Mental Illness

Persons with serious mental illness (SMI) experience one of the largest health disparities in the U.S., with
mortality rates two to three times higher than the overall population. Much of this premature death is
attributable to cardiovascular disease (CVD), driven by elevated rates of CVD risks (unhealthy diet, physical
inactivity, tobacco smoking, obesity, hypertension, diabetes, and dyslipidemia) influenced by interconnected
biologic, health behavior, and contextual (e.g., system, policy) factors. Despite the existence of tailored,
effective interventions to decrease CVD risk in people with SMI, adoption of these interventions remains
limited, contributing to thousands of potentially preventable deaths a year. Our ALACRITY Center was
originally created in response to this extraordinary burden of years of life lost and has used cutting-edge
transdisciplinary methods to develop and pilot test strategies and conduct methods innovations work to scale
practical, effective interventions aimed at reducing CVD risk in this population. In our new application for the
Center to Accelerate Translation of Interventions to Decrease Premature Mortality in Persons with Serious
Mental Illness, our goal is to continue to build on this foundational work and amplify the Center’s impact
through an enhanced focus on health equity, partnership engagement, methods innovations, and building
capacity amongst mental health researchers and community partners to improve physical health for persons
with SMI. Our uniquely qualified and diverse team will conduct a signature R01 and three R34s to rigorously
plan, test, and model implementation strategies addressing all CVD risks in persons with SMI in community
settings. We propose: 1) conducting an implementation trial of a behavioral weight loss intervention in two
states; 2) piloting a system-level strategy for a CVD risk factor care evidence bundle tailored to people with
SMI in primary care; 3) developing and piloting strategies to scale a healthy weight intervention in youth; and
4) systems modeling to inform scaling of evidence-based tobacco cessation treatment in community mental
health settings. The Methods Core will grow its transdisciplinary approach incorporating clinical and behavioral
intervention research, implementation science, biostatistics, systems science, and health services and policy
research to support Center work, and advance methods in: 1) developing a policy implementation
measurement framework; 2) identifying implementation strategies’ core components; 3) improving the
precision and robustness of implementation trials; and 4) building “hybrid” systems models in implementation
science. The Administrative Core will engage partners, building on its well-established Community Advisory
Board, lead Center-wide health equity efforts, and bring together all Center activities. The grave disparities in
life expectancy and CVD risk burden in persons with SMI call for continued, concentrated, transdisciplinary
approaches to solutions. Our Center provides a nexus of innovation and momentum around T3 translation, and
the proposed work will make important, needed contributions to advance health equity for persons with SMI.

Public health relevance
Project Narrative Persons with serious mental illness (SMI) experience one of the largest health disparities in the U.S., dying 10 to 20 years earlier than the overall population, primarily due to cardiovascular disease. The proposed Center to Accelerate Translation of Interventions to Decrease Premature Mortality in Persons with SMI will study implementation strategies to scale-up effective interventions to address cardiovascular risk behaviors (unhealthy diet, physical inactivity, tobacco smoking) and risk factors (obesity, hypertension, diabetes and dyslipidemia) among persons with SMI, with an explicit focus on health equity, partner engagement, methods innovations, and building capacity amongst researchers and community partners to enact our Center’s mission – to advance health equity so that persons with SMI can live long healthy lives.